ROLE OF BISPHOSPHONATE THERAPY IN MAINTENANCE OF SKELETAL INTEGRITY

Tests whether bisphosphonate (daily oral alendronate) therapy maintains femoral and vertebral bone mass in women over 65 years old.